GROWTH HORMONE TO TREAT HYPOGLYCEMIA IN PATIENTS WITH METASTATIC INSULINOMAS

To determine in this pilot study whether growth hormone can decrease the frequency of low blood sugar in patients with malignant insulinoma.